A Humanized Monoclonal FSH Blocking Antibody for Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) stands out as notable in not having a cure among many diseases that affect
elderly men and women––in essence, creating an urgent need for a new therapy. It is also unclear why
menopausal women have a preponderance of AD, and, while declining estrogen bas been implicated, there is
clear clinical correlation with rising levels of follicle stimulating hormone (FSH). We have identified FSH as a
target for several aging disorders––osteoporosis, obesity, hypercholesteremia––and now, AD. Inhibiting the
action of FSH using blocking antibodies reduces body fat, increases bone mass, lowers serum cholesterol, and
from our newest and most exciting results, prevents AD in two mouse models. We have designed a novel
humanized monoclonal antibody, Hu6, that binds to a small epitope within the receptor–binding domain of FSHβ,
thus blocking its action on the FSH receptor (FSHR). Our aspirational goal is to use this lead therapeutic for
the therapy and prevention of all four disorders––or, at the very least, AD. Selected from a pool of 30 newly
synthesized humanized antibodies, Hu6 displays high–affinity binding to FSH (KD ~7 nM) and thus prevents its
action on hippocampal FSHRs to improve cognition in AD mice. These observations, together with its optimal
pharmacokinetic profile, lay the groundwork for Hu6 to enter early stage development. In Specific Aim 1, we
propose to scale up production of research–grade Hu6; create an optimal formulation; test its physicochemical
properties; study the structure of the FSH:Hu6 complex; and manufacture a master cell bank for cGMP–grade
Hu6. In Specific Aim 2, we will perform pharmacokinetic studies in Tg32 mice ‘humanized’ for antibody
clearance, and in African green vervet monkeys; determine minimum effective dose(s) in preventing and/or
treating AD in 3xTg mice; examine efficacy and safety in young and aged 3xTg mice; and document safety in
vervet monkeys. The work will be conducted using Good Laboratory Practice (GLP) standards established at
Mount Sinai, Emory, Wake Forest and San Antonio. We have also created cross–functional research teams that
will be supported by a distinguished panel of advisors, comprising science and medicine experts, business
leaders, and entrepreneurs in biotechnology. Definitive information on dosage, route and frequency, together
with early proof of safety should propel us into late stage development and first–in–human studies.

Public health relevance
PROJECT SUMMARY We have identified follicle stimulating hormone (FSH) as a new target for treating Alzheimer’s disease, along with three other crippling diseases of the aging population, namely osteoporosis, obesity and high cholesterol. For this, we have designed a lead therapeutic antibody to FSH, which we will take through early stage development in this proposal. This should provide us with critical pieces of information on the likely dose, route and frequency of administration, allowing it to move through the late stage development pipeline into clinical trials.